Transformable Theranostics for imaging-guided interventions in head and neck squamous cell carcinoma

Title: Transformable Theranostics for imaging-guided interventions in head and neck squamous cell
carcinoma
Summary/Abstract
The overall goal of this Phase II SBIR proposal is to translate our highly effective and non-toxic Transformable
Nano-Theranostics (TNTs) into clinical trials for precision image-guided intervention of head and neck squamous
cell carcinoma (HNSCC). HNSCC is the sixth most common cancer worldwide. There are around 550,000 new
cases worldwide annually and 65,630 cases in the U.S. alone. The overall survival rate of HNSCC remains
unchanged over the past 25 years. Tumor recurrence and metastasis are the leading causes of mortality.
Patients with recurrent or metastatic HNSCC have a median overall survival of only 10 months. Even with
intensive surgery, radiotherapy and chemotherapy, prognosis for these patients is still dismal. Complete surgical
removal (with negative margins) is the goal of the treatment, but can be difficult to achieve due to the infiltration
of vital structures. Since positive surgery margin is associated with poor prognosis, there is a great need to
develop novel treatments which can not only guide surgery but also destroy any residual cancer while sparing
critical organ structure and function. Moreover, development of theranostic agents that can detect and eliminate
early HNSCC lesions, particularly aggressive sub-types, could have tremendous impact in survival and function
for many patients. We recently developed a set of highly innovative TNTs that possess outstanding capability to
circumvent the sequential biological barriers which have generally hindered drug delivery to tumors, including
HNSCC. In our Phase I SBIR grant, we have optimized TNTs and demonstrated that 1) the smart dual
size/charge- transformation of TNTs in response to ubiquitous hallmarks of tumors (e.g. tumor acidosis induced
acidic extracellular pH, pHe) dramatically increased the tumor accumulation and penetration of TNTs in HNSCC
tissue, and facilitated uptake in cancer cells; 2) TNTs enabled effective visualization of tumor, drug delivery and
therapeutic effect by near infrared fluorescence imaging (NIRFI) and magnetic resonance imaging (MRI); 3) the
synergistic trimodal therapy via TNTs achieved a 100% complete cure rate in orthotopic HNSCC mouse models.
Those promising results built a solid foundation for us to move forward to the SBIR Phase II project, in which we
plan to 1) synthesize large scale Good Manufactory Production (GMP) grade TNTs, 2) perform Investigation
New Drug (IND) enabling pharmacology and toxicology studies in two species (dog and rodent), and 3) draft IND
application and design a phase I first-in-human clinical trial for HNSCC patients to determine the dose for phase
II. Our long-term goal is to develop safe, highly efficacious and cost-effective theranostic agents for human
HNSCC. The successful completion of this research will make the proposed TNTs ready for clinical trials. The
proposed transformable, tumor hallmark targeting yet easy-to-make nano-theranostic agents that are highly
capable of overcoming the important barriers for drug delivery to HNSCC offer tremendous opportunities for
precision image-guided intervention of HNSCC, therefore have great pharmacological, clinical and commercial
potentials to lead to a marketable nano-formulation to improve the treatment of HNSCC.

Public health relevance
Narrative The proposed transformable Nano-Theranostics shows great promise to improve imaging sensitivity/specificity and drug delivery efficiency to HNSCC and are expected to be highly useful in precision image-guided treatment for effective detection and elimination of early localized HNSCC lesions. For larger HNSCC that require surgical resection, it can be used as a theranostic agent for (i) delineation of tumor margin for image-guided surgery, (ii) intra-operative phototherapy to treat any residual diseases at the surgical margin and adjacent sites that are accessible to illumination intra-operatively, and (iii) systemic treatment of lesions that are not accessible to illumination if using full dose anti-cancer drug within the transformable nano-theranostics. This project will significantly lower the mortality among patients with HNSCC and will have a tremendous impact on the quality of life of these patients.